The three-dimensional spatiotemporal dynamics of human uterine contractions using electromyometrical imaging (EMMI)

Summary/Abstract
We have limited understanding of how uterine contractions develop and become sufficiently coordinated to expel
the fetus at term. For example, we lack answers to basic questions about labor such as where contractions
initiate, how fast contractions propagate, which regions of the uterus are active during contractions, and how
these measures change as labor progresses. To address this knowledge gap, a new imaging technology,
Electromyometrial Imaging (EMMI) was recently developed and validated in a translational sheep model. EMMI
employs magnetic resonance imaging to acquire a subject-specific body-uterus geometry, then combines the
resulting data with electrophysiological data collected from up to 256 electrodes on the abdominal surface. With
EMMI, it is possible to noninvasively image the electrical activation and conduction patterns during contractions
across the entire uterus in three dimensions. Preliminary data indicate that EMMI can be used to systematically
characterize contractions during normal term labor in humans. Additionally, three proposed features of uterine
electrical activity, termed "contraction indices", appear to correlate with time until delivery. The objectives of this
proposal are to use EMMI to create a "normal term atlas" describing the 3D electrical activation patterns of
human uterine contractions at high spatial and temporal resolution across labor, and to use this atlas to begin to
identify contraction features associated with impending labor arrest. Aim 1 is to define the uterine electrical
maturation and contraction patterns during labor in term nulliparous women. In this Aim, EMMI will be conducted
on 430 nulliparous women throughout labor, and data will be analyzed from the 365 women who are anticipated
to have normal term labor. This aim tests the hypothesis that at least one of the EMMI-derived uterine contraction
indices can precisely reflect progression of normal term labor in nulliparous women, and can reliably differentiate
the different phases of the first stage of labor. Exploratory Aim 2 will evaluate uterine electrical contraction
patterns during labor in the anticipated 75 women from Aim1 who experience labor arrest. This exploratory aim
will provide the basis for a future larger EMMI study to fully characterize the spatial-temporal signatures of uterine
contractions in patients who develop arrested labor. In completing these two aims, this project will generate
physiologically normal standards of uterine contraction indices of nulliparous women during the progress of term
labor. These normal standards will permit future in-depth clinical investigations of the factors leading to
dysfunctional labor. Moreover, they may, in the longer term, serve as standards for monitoring pregnancy and
labor progression and assessing the effectiveness of treatment strategies to manage labor and prevent labor
complications such as preterm birth, labor arrest, and postpartum hemorrhage.

Public health relevance
Project Narrative Although approximately 130 million babies are born every year worldwide, we have limited understanding of how normal term labor progresses. This project will use a recently developed technology (Electromyometrial Imaging, EMMI) to build the first-ever "normal term atlas" describing the detailed electrophysiology of uterine contractions during normal term labor. In the long term, EMMI holds great potential to monitor labor and test the effectiveness of strategies to reduce labor complications.